MOLECULAR EVENTS IN FERTILIZATION

We will use gametes of the sea urchin, Stronglyocentrotus purpuratus, as a model system to analyze biochemical aspects of the cortical and acrosome reactions, processes that are common to many fertilization systems. In studying the cortical reaction and the modification of the egg coat that accompanies it we will extend our results on the role of a peroxidative system that hardens the fertilization membrane. We shall characterize the ovoperoxidase released from the cortical granules and to be inserted into the fertilization membrane, and we will study the specific assembly of that structure, as well as its crosslinking in vitro. We will explore the mechanism of generation of activated oxygen species produced in the oxidative burst that act as substrates for ovoperoxidase and how the burst is regulated. We shall see whether a vesicular system exists in eggs for uptake and release of Ca2 ion, analogous to the sarcoplasmic reticulum of muscle, and whether it is involved in the Ca2 ion-mediated cortical reaction. We will pursue the ionic mechanism of triggering the acrosome reaction of sperm, by examining whether elevations in intracellular pH and calcium are the two steps that are necessary and sufficient for triggering the reaction. We will examine the mechanism of interaction of individual jelly components with sperm, to see whether distinct components mediate specific ion fluxes. These experiments should provide insights into molecular mechanisms of several important events in fertilization and thereby indicate novel targets for the control of fertility.